Administrative Core

Project Summary
Administrative Core
The Administrative Core of the Integrative Neuroscience COBRE will be directed by the COBRE program
director and assisted by the administrative program officer. This core will oversee all aspects of management,
evaluation, and strategic planning for the center and the associated cores and pilot program. It will organize the
meetings of the Executive Committee (composed of the core and pilot directors) the Steering Committee
(Executive Committee plus university administration and core user representatives), and the External Advisory
Committee, and will implement the recommendations from these advisory committees. The Administrative
Core will prepare progress reports and provide these for the External Advisory Committee and NIGMS. It will
serve as a liaison between the COBRE and the University of Nevada, Reno (UNR), other UNR COBRE’s, and
the Nevada IDeA Network of Biomedical Research Excellence (INBRE) program. It will also serve to
strategically connect the COBRE to the Institute for Neuroscience and neuroscience training initiatives
including the Graduate Program in Integrative Neuroscience. The Administrative Core will also provide full
logistical and administrative support for both the pilot project program and the core facilities, and the planning
and implementation of business models for transitioning the cores to user- or institution-funded facilities. This
will include maintaining the budget, employee records, and equipment inventories, support for human and
animal protocols, and support for grants and grant reports. The core will administer travel funds for training and
for attending the annual meetings of the National Institute of General Medical Sciences, and will support the
seminar series to bring leading investigators to UNR to discuss their work. Finally, this core will be responsible
for the ongoing evaluation and assessment of the COBRE. The core will be based in space in the Psychology
Building (Mack Social Science), in space contiguous with the Neuroimaging Core, very close to the offices and
labs of the program director and all 12 of the cognitive neuroscience faculty labs in Psychology.

Public health relevance
Project Narrative Administrative Core The Administrative Core will coordinate and implement the overall management, evaluation, and strategic planning for all aspects of the center including the research cores and pilot project program.